LEUKOTRIENE D4-INDUCED BRONCHOCONSTRICTION

This study is designed to test the effectiveness of a novel, potent leukotriene-receptor antagonist, ICI 204,219, in blocking leukotriene D4- induced bronchoconstriction in normal subjects.